Technology Core

ABSTRACT
The Technology and Data Management (TDM) Core serves two primary functions that are essential for the
success of the EAS program project: (1) the management and integration of data, and (2) providing
consultative and technical support for data operations. The aims of the TDM Core are as follow: Aim 1. To
implement and oversee a central data repository and pipeline to facilitate the seamless exchange, integration
and management of data among EAS Cores and Projects. Aim 2. To provide consultative and technical
support to facilitate data collection and integration from different data sources (e.g., clinic, self-reports,
wearable devices, sensors, biomarkers), and execute an operation plan for running and maintaining the central
data infrastructure and management system. Aim 3. To score and evaluate basic psychometric properties
(e.g., items and scores distributions, correlations, reliability) of clinical measures, conventional psychosocial
scales and ambulatory assessments across Projects in order to provide tidy and analysis-ready datasets for
further validation and analyses in the Statistical Core. Aim 4. To support and facilitate data dissemination and
consortium collaborations with the scientific community and the public. In line with NIH Policy for data
management and sharing (NOT-OD-21-013), and following the governance procedures distributed by the
Dissemination Committee, the TDM Core will support the sharing of data, protocols, measurement and testing
procedures, and relevant data dictionaries with the broader research community and lay public, by depositing
data and metadata using various established repositories and platforms. The TDM Core follows the FAIR
principles for scientific data management (Findable, Accessible, Interoperable, and Reusable), and will develop
and operate a central data management and technical support system that will meet the scientific aims and
research needs of the EAS P01, while also facilitating collaborations and dissemination with the broader
research community and public.

Public health relevance
NARRATIVE: The Technology and Data Management (TDM) Core TDM Core develops and maintains a secure, central data repository and management system for efficiently managing the vast, diverse data collected in EAS Program Project, and provides consultative and technical support for all data operations. These functions of TDM Core are essential for the success of the EAS Program Project and will facilitate data sharing, dissemination and collaborations amongst the EAS team, with external collaborators, and with the broader research community.